MONILIAL DIAPER DERMATITIS IN INFANTS AND MATERNAL COLONIZATION

Relationship between the incidence of mothers who are colonized with yeast and their babies who are infected. If higher proportion of women with monilia infected babies themselves have a yeast infection, we propose that the mother is passing the infection to her child, either by colonization during the vaginal delivery or by poor hygiene techniques in caretaking.